Early Detection Of Renal Injury

We published a paper with a HESI group examining the levels of several miRNAs in urine from macaques, which were subjected to a nephrotoxic treatment, comparing histology scores to the miRNA in unfractionated urine or the exosomal fraction. Remarkably, given the small sample size, there was good correlation between urine miRNA and histology. There was also good correlation between all exosomal miRNAs. This study was a demonstration of a re-examination of samples already collected from animal experiments, which reduced the number of animals used while gaining new insights.

1) We are continuing our work on exosomes as a source of biomarkers, including proteins and miRNA. We are exploring proper normalizing techniques for these biomarkers, including counting exosomes by Nanosight Tracking Analysis. We are also exploring subsets of urine exosomes that may derive from different segments fo the nephron.

3) We are continuing our collaboration with HESI on miRNA biomarkers for kidney and liver toxicity.

4) We are continuing our work on sepsis and sepsis-AKI with two new biomarkers, one for each.

5) We are continuing our collaboration to look at two related biomarkers that can be elevated in the plasma of lung transplant rejection patients.